Regulation of T cell ligand discrimination by tuning the phosphorylation kinetics of Zap70 substrates

PROJECT SUMMARY/ABSTRACT
This NIAID K22 Career Transition Award focuses on the long-term research goals of the candidate, Dr. Wan-
Lin Lo, to become an independent investigator and to acquire data for a future R01 application. This proposal
focuses on the examination of T cell ligand discrimination capability through manipulating phosphorylation
efficiency of Zap70 substrates. Upon TCR stimulation, the activated T cell kinase Lck phosphorylates tyrosines
on CD3 and z-chains, leading to the recruitment, phosphorylation and activation of the kinase Zap70. Activated
Zap70 subsequently phosphorylates multiple sites within the adaptors LAT and SLP76. Phospho-tyrosines on
LAT and SLP76 become docking sites for additional signaling proteins, resulting in LAT- or SLP76-based
signalosomes. There are five Zap70 substrate tyrosines in LAT, and three in SLP76. Each of these tyrosine
substrates is dedicated to specifically interact with distinct proteins that are involved in divergent downstream
pathways. For example, phosphorylation of LAT Y132 is the only tyrosine that can couple TCR signals to the
PLCg1 pathway and the resultant calcium increase. Previously, it was thought that phosphorylation of Zap70
tyrosine substrates was strictly a signal propagation step that diversifies or amplifies signals. However, Dr. Lo’s
preliminary data showed that, at least for LAT Y132, Zap70-mediated phosphorylation of this site has greater
significance. Zap70-mediated phosphorylation of LAT Y132 has uniquely slow phosphorylation kinetics. This is
because the amino acid preceding Y132 is a glycine, whereas other Zap70 substrates contain a negatively
charged amino acid at this position which complements Zap70’s positively charged docking site. By replacing
this glycine with a negatively charged residue, Dr. Lo observed faster phosphorylation of Y132, and yet this
allowed T cells to inappropriately react to weakly binding self-antigens. Dr. Lo hypothesizes that LAT Y132 has
evolved to serve as a unique TCR signal bottleneck to support a proper degree of T cell ligand discrimination.
To test this hypothesis, she will explore whether the Y132-phosphorylation-PLCg1 bottleneck is really uniquely
suited for ligand discrimination by examining whether the phosphorylation kinetics of other Zap70 tyrosine
substrates can have similar effects on T cell’s ability to discriminate self and non-self (Aim I). She will also slow
down the phosphorylation speed of other Zap70 substrates, by mutating the preceding negatively charged
residue to a glycine. This mutagenesis approach will impose “Y132-like” slow kinetics on other Zap70 tyrosine
substrates, to test whether these nodes can also serve as kinetic bottlenecks and affect ligand discrimination.
She will also evaluate T cell development and peripheral T cell function in a LAT G135D knock-in mouse
(glycine to glutamate mutation preceding Y136, homologous to human G131-Y132), to determine how
disruption of this kinetic threshold impacts thymic T cell selection and T cell tolerance in vivo (Aim II). The
obtained data will provide insights into how T cell ligand discrimination is regulated and will establish the
foundation of new research projects for Dr. Lo’s independent scientific career.

Public health relevance
PROJECT NARRATIVE A defining characteristic of the vertebrate adaptive immune system is its ability to discriminate self from non- self, which is based on antigen receptors’ ability to differentially trigger intracellular signaling pathways in response to weak self-ligands versus stronger foreign ligands. This proposal is built on the recent discovery of a previously unknown signal proofreading event, the slow but critical phosphorylation of a specific tyrosine, Y132, in the T cell scaffold protein LAT. The proposed studies aim to define how this mechanism enables T cells’ ligand discrimination, and will reveal the importance of this and other instances of kinase-mediated kinetic proofreading in distinguishing self from non-self.